Career-Enh-Prog-001

The primary objective of the Glioma SPORE Career Enhancement Program (CEP) is to attract talented new
investigators to translational glioma research. Potential CEP awardees include junior faculty beginning their
careers or established faculty members in other fields who wish to redirect their interests and efforts to glioma
research. We will maintain a comprehensive, system-wide process for solicitation of CEP applications and an
expert-based review process to select the most meritorious applicants. The CEP program faculty consists of a
multidisciplinary cohort of experienced, senior mentors for CEP awardees. The CEP provides limited-duration
funding for promising, junior translational investigators who are focused on glioma research. The program will
provide support, mentoring and monitoring for CEP awardees. We will maintain a monitoring process to
measure progress and outcomes of CEP awardees and the CEP program. We carefully monitor the progress
of CEP awardees through clearly enumerated metrics on a biannual basis. The overall Career Enhancement
Program is assessed on an annual basis by the internal and external advisory boards. The CEP leverages
institutional resources to support and enhance the success of the program.

Public health relevance
The Career Enhancement Program provides research support for junior or new investigators in the field of glioma research. Through support, mentoring and monitoring the program enables awardees to embark on successful careers in glioma research that will ultimately benefit patients.